Scientific Outreach Component

SOC The Scientific Outreach Component (SOC) will further develop the exRNA Portal to disseminate and provide for visualization of the exRNA Atlas data; ensure accessibility of ERCP-generated resources and protocols; and initiate community engagement in exRNA biology using workshops, presentations, and social media. We will develop topic-specific workshops to be held at Consortium meetings, but also engage with scientific societies to co-locate workshops at major scientific conferences. SOC established an ERCC Twitter following over the last several years and we will seek to expand our followers by live tweeting from scientific conferences and workshops, further communicating about ERCC achievements, and tweeting about ERCC publications, protocols, and events. We will also continue the ERCC blogging program and create online videos where researchers share their experiences in the exRNA field.